BRING-IT: Biomedical Research Investing in Growth and ISU Talent

PROJECT SUMMARY
Idaho State University (ISU) is a resource-limited, regional, R2 doctoral-granting institution in a rural, Mountain
West state. As the state’s designated lead for training in the health professions and a participating member of
the statewide Idaho INBRE program (NIH IDeA Network of Biomedical Research Excellence), ISU has
significant potential for growing its biomedical research portfolio. To build toward a stronger future in
biomedical research, ISU needs a clear picture of the institutional capacity and research environment. A needs
assessment and an action plan that specifically hones in on strengthening the biomedical research enterprise
has never happened at ISU, and it is much needed. Our long-term goals are to strengthen biomedical research
infrastructure at ISU and to create a research environment where faculty and students in the biomedical
sciences can flourish. The objective of BRING-IT: Biomedical Research Investing in Growth and ISU Talent is
to develop an institution-wide and data-informed action plan that will guide improvements in biomedical
research capacity. University leadership will champion the action plan, which will be developed by institutional
collaborators at different levels of the research enterprise. To attain the objective of this application, we will
create a practical roadmap, with both short-term and long-term goals, for strengthening the future of biomedical
research at ISU in ways that will lead the institution and faculty to be more competitive for NIH funding.
Institutional leadership is committed to seeing through implementation of the action plan. The overall impact
will reverberate across the university, with ISU becoming better positioned to secure individual research project
grants (e.g., R01s), as well as capacity-building grants (e.g., COBREs and CTRs). Outcomes are expected to
have a positive impact on faculty research support and professional development, student training
opportunities, institutional research culture, and research infrastructure.

Public health relevance
NARRATIVE Idaho State University’s BRING-IT: Biomedical Research Investing in Growth and ISU Talent team will develop an institution-wide and data-informed action plan based on a systematic needs assessment that will guide improvements in biomedical research capacity. Campus-wide collaborators include: a steering committee (project PIs and university research and academic leadership), members of the ISU Leadership Council, Research Council of Faculty Senate, and the Office for Research. As Idaho’s designated lead institution in health professions, our long-term goals are to strengthen ISU’s biomedical research infrastructure and create a research environment where faculty and students in the biomedical sciences can flourish.